Archiving Nuptiality Pandemic Data

Abstract
Despite the impact of the COVID-19 Pandemic and the varying state-level mitigation policies it triggered much
remains unknown regarding the effects on a multitude of life domains, including the health and well-being of
American families. There is a need for more dynamic and timely data to track how Americans are responding to
the pandemic. Due to the deterioration and defunding of the marriage and divorce vital statistics system, recent
monthly state-level marriage and divorce data are not available from one source in analysis-friendly formats
crippling our capacity to understand geographic variation in marriage and divorce at an unprecedented time in
world history. While the availability of some health and vital statistics data has become widespread throughout
this crisis, high-quality data on the pandemic effects on marriage behavior have not been accessible, let alone
kept pace. Existing survey data, such as that collected via the American Community Survey has been
compromised due to low response rates and high nonresponse bias. Further, they do not provide monthly data.
No centralized location or agency is responsible for providing monthly administrative data on marriage and
divorce at the state level. Calls for attention on the effects of structural determinants (e.g., political, legal, policy,
and economic) at the state-level have come from several constituent groups. Despite the spotlighted importance
of state-level, timely data, and efforts of individual researchers to fill this gap, dynamic temporal, and spatial
variation in how the pandemic has affected marriage and divorce patterns since March of 2020 remain unknown.
Our objective is to continue our past efforts in archiving administrative marriages and divorce data and expand
those efforts to archive monthly state-level marriage and divorce counts, compute monthly adjusted marriage
and divorce rates at the state-level and disseminate these data in widely accessible manner enabling the usage
by the broader research community, program staff, and practitioner communities. These efforts will enable
researchers to link marriage and divorce data to existing data—a specifical designated purpose of this program
announcement. Our third and final aim will be to disseminate the data via the National Center for Family &
Marriage Research and the Data Sharing for Demographic Research websites. The dissemination will increase
awareness of these valuable data across many potential data users. This innovative project fits squarely with
the PDB mission to enhance knowledge and data availability on families and households. This, in turn, is
expected to enhance currently available data and increase their potential scientific impact through increased
accessibility and efficiency. The application is consistent with the purpose of the R03 mechanism and this specific
program announcement and will offer a resource to a multidisciplinary set of researchers, policy makers, and
practitioners.

Public health relevance
Narrative Healthy People 2030 stresses the importance of the social determinants of health, including the family and the COVID-19 Pandemic has brought emphasis to the effects of structural determinants of health. Our goals fit squarely within the vision of the NICHD and specifically the Population Dynamics Branch (PDB) to help understand changes—including new challenges—shaping families and provide data useful for timely assessments of community health. These data will provide researchers and practitioners monthly point-in-time estimates of social and community context—an effective tool for understanding the changing landscape of marriage and families in the United States and its effect on health.